Project 1: Oocyte Developmental Competence and Aging

PROJECT SUMMARY/ABSTRACT
With the progressive delaying of childbearing age in western society, understanding and treating the decline in
women's fertility associated with aging is becoming increasingly important. While the causes of premature aging
of the ovary compared to other organs are largely unknown, it is widely accepted that a decline in oocyte
competence to develop as an embryo is central to the decline in fertility in women over thirty-five. Several causes
are thought to be at the basis of this decreased oocyte quality, the most widely accepted being an increase in
age-related aneuploidy. Oocyte competence to complete meiosis and to develop as an embryo depends on
complex programs of gene expression. At the end of its growth, oocyte's transcription is silenced and the control
of gene expression is transferred to the cytoplasm, where a program of selective translation of maternal mRNA
is executed. Thus, translational regulation is essential for the oocyte to become developmentally competent. Our
laboratory has shown that this translation program activated in the final stages of oocyte maturation plays a
critical role for the progression through the meiotic cell cycle, for chromosome trafficking and for preimplantation
embryo development. Here we propose to test the hypothesis that this oocyte translation program becomes
progressively defective during female aging. Preliminary data exploring the translation of candidate maternal
mRNAs in oocytes from aging mouse females support this hypothesis. We propose to further these studies by
exploring the functionality of the translation program during aging in mice and humans. The first Specific Aim
will compare the pattern of maternal mRNA translation in oocytes from young and old females. We will use a
mouse model where ribosomes are tagged in the oocyte, and translating mRNAs will be isolated by
immunoprecipitation of ribosome/mRNA complexes followed by RNA-Seq. This genome-wide approach will
define the extent of translational defects that develop with oocyte aging. The second Specific Aim will be devoted
to understanding the molecular mechanisms at the basis of this defective translation. On the basis of genome-
wide data suggesting defective expression of RNA binding protein networks and polyadenylation machinery, we
will investigate the functionality of these components in aging oocytes. With the third Specific Aim, we will test
the hypothesis that disruption of the translational program recapitulates the phenotype associated with aging.
We will use genetic models of haploinsufficiency and SiRNA mediated knockdown to destabilize the translational
program in young oocytes and determine whether oocyte developmental competence is compromised as it is
during aging. To consolidate these findings, we will relate the observations made in a rodent model to human
oocytes. We will explore whether translation is defective in oocytes from aging women and explore whether
defects in biomarkers of translation are present using single cell assays. If confirmed, the hypothesis of
compromised translation will open new avenues for understanding the decline in fertility in aging women and for
developing new therapies.

Public health relevance
PROJECT NARRATIVE The progressive decrease in fertility associated female aging is becoming a major social issue in Western countries. Considerable evidence points to a decline in oocyte quality as the major cause of the aging-related infertility. Understanding how oocyte quality becomes compromised with aging of a female is therefore central to women's health. Based on observations in rodents, we propose the novel hypothesis that defective gene expression consequent to compromised mRNA translation causes the decline in oocyte quality during aging. Exploring how mRNA translation is defective will provide new molecular correlates of oocyte quality and will pave the way to develop novel strategies to improve oocyte quality from older women.